Magnesium flux compendium: Discover ligands, channels, and metabolic signals

ABSTRACT/SUMMARY
Free ionized intracellular Mg2+ (iMg2+) is estimated to be in the range of 0.5–1.2 mM. In general, it is accepted
that under resting conditions, the concentration of ionized cytosolic Mg2+ is `muffled' by phosphometabolites,
nucleic acids and proteins. For example, ATP binds with a Kd value of 50 μM-70 μM and therefore Mg2+ in the
cytosol and the mitochondrial matrix is primarily complexed with ATP (Mg-ATP2-). Because of its abundance (~5
mM), ATP is considered to be the largest iMg2+ `store'. Fluctuations in free cytosolic (cMg2+) following hormonal
stimuli have been touted as passive adjustments of Mg2+ dissociating from the exuberant Mg-ATP contingent
and other `buffered' pools of Mg2+. Apart from iMg2+ `buffering' mechanism, Mg2+ ion channels and transporters
controlling Mg2+ entry as well as efflux across the plasma membrane are thought to maintain the equilibrium of
free cMg2+. Currently, several candidates are correlated to Mg2+ entry machinery (TRPM6, TRPM7, MagT1), but
are still awaiting convincing biophysical and physiological evidence for such roles. The Mg2+/Na+ exchanger
SLC41A1 was proposed to contribute Mg2+ efflux from the cell, whereas Mrs2 was proposed as a mitochondrial
Mg2+ transporter. Very little is known about the molecular details of Mg2+ transport into/from cellular organelles
like the ER, mitochondria, endosomes and lysosomes. A few studies have speculated that free [Mg2+] in the ER
and mitochondria are likely to be similar to [cMg2+]. However, the temporal and spatial dynamics, let alone the
biological relevance of iMg2+ mobilization, remain a mystery in cell biology. Nevertheless, Mg2+ is an essential
cation controlling many biochemical reactions. Our recent work has shown that L-lactate acts as an activator that
triggers a dynamic transfer of Mg2+ between the ER and mitochondria to shape bioenergetics and cellular
metabolism (Cell 2020). Mechanistically, L-lactate stimulates Mg2+ release from the ER followed by Mg2+ uptake
by mitochondria. The mitochondrial localized Mrs2 transporter was found to be responsible for the accumulation
of Mg2+ in mitochondria. However, the L-lactate-induced ER release molecular machinery remains unidentified.
I propose to identify ER Mg2+ release component, plasma membrane entry machinery and the resultant
molecular signaling pathways. I will take advantage of unbiased RNAi screen and targeted CRISPR/Cas9 editing
approaches to answer these mysteries in the Mg2+ signaling field. Identification of these molecular machineries
would aid in our understanding of iMg2+ dynamics and the cause-effect relationships that exist between iMg2+ flux
and cellular processes. Additionally, I will test and define the Mg2+-dependent signaling events based on the
cellular and mouse model phenotypes. It is thrilling to define the molecular link between cellular Mg2+
homeostasis and physiological function. Our identification and characterization of the Mg2+ flux components will
further investigate how, and if, these signaling routes impinge on the pathophysiology of a growing number of
Mg2+ deficiency diseases in humankind. Overall, the R35/MIRA funding will support the testing of this
unconventional hypothesis and my laboratory will address these major mysteries in the near future.

Public health relevance
NARRATIVE Mg2+ is essential for wide range of cellular processes including the imposition of membrane shape and stability, neutralization and stabilization of nucleic acids and nucleotides, channel modulation, enzyme secretion from acinar cells, and serves as a cofactor for cytosolic and mitochondrial metabolic enzymes. Although cellular Mg2+ dynamics is accomplished via numerous Mg2+ transport machineries, the molecular identity of these Mg2+ flux mechanisms have not been fully elucidated. In the MIRA program, we will identify ligands and channels and elucidate Mg2+-dependent metabolic signals that would establish the Mg2+ flux compendium.